Skin Lesion Archive and Annotation for Fusion and Earlier Skin Cancer Detection

Invasive malignant melanoma has risen in incidence for decades. Dermoscopy aids in detection of the earliest
and most curable stage of melanoma. The long lead times required for appointments with specialists trained in
dermoscopy and a lack of dermoscopy training for mid-level practitioners, often the first to encounter a
melanoma, contribute to a delay in melanoma detection at the most curable stage. Recent advances in
classifier architectures and computing power have enabled development of advanced image-processing tools
to improve diagnostic accuracy, exceeding that of dermatologists. Extensive collections of dermoscopy images
are available to enable better training for deep learning computational techniques. However, automated
methods still need to provide sufficient accuracy for reliable melanoma screening for in-person and virtual
consultations. Computational techniques are less successful for limited data sets, such as those of specific
features. Our hypothesis is: Annotation of critical skin lesion structures for small-scale data sets by multiple
experts enables automatic structure detection that can improve automatic lesion discrimination ability.
To investigate this hypothesis, the proposed three-year project is a collaboration with the largest
publicly available skin lesion image archive to create a platform that promotes international participation in
dataset annotation, curation, and validation to facilitate advances in skin lesion analysis research. This platform
will allow global experts to annotate and validate dermoscopic skin lesion image datasets to identify and
segment critical structures, providing an archive integrated into the publicly accessible International Skin
Imaging Collaborative (ISIC) image collection. Skin lesion feature analysis and validation studies will be
conducted to identify critical features contributing to improved melanoma discrimination from benign mimics.
The proposed research will investigate the fusion of existing deep learning techniques based on the entire skin
lesion with deep learning techniques trained using localized annotation information for guided deep learning of
specific skin lesion structures for feature extraction and diagnosis. We will perform statistical analyses to
determine relevant annotated skin lesion small-scale feature set sizes and the significance of feature detection
and diagnostic rates between standard deep learning techniques, targeted localized feature set-based guided
deep learning training, and fused (combined) results for hypothesis assessment. Hypothesis-driven feature
detection and diagnosis results from this study will impact small-scale dataset analysis for deep learning
algorithm development. As part of the proposed project, seminars will be provided to pre-college students
through STEM programs such as Project Lead the Way. Further educational and training opportunities will be
provided to undergraduate students pursuing pre-med, biological sciences, data sciences, and biomedical
engineering programs through seminars, summer camps, and hands-on mentored research opportunities.

Public health relevance
Deep learning diagnostic accuracy for dermoscopic images can exceed that of dermatologists, however it fails to provide sufficient accuracy to serve as a reliable screening tool for in-person and virtual consultations and automatic triage of lesions. To improve diagnostic accuracy for skin lesion images, we propose an enhanced, publicly accessible database of critical skin lesion structures through expert annotation and curation of thousands of images, enabling a new paradigm for the automatic analysis of cancer images and providing a transparent foundation for cancer image processing. This three-year project will provide educational opportunities for undergraduate students in multiple fields of study at Missouri University of Science and Technology and pre-college STEM outreach educational initiatives.